Perivascular Inflammation and Vascular Remodeling: A Common Cause of Hemorrhage in Cerebral Small Vessel Diseases?

Project Summary / Abstract
Title project: “Perivascular inflammation and vascular remodeling: a common cause of hemorrhage in cerebral
small vessel diseases?”
Cerebral small vessel disease (CSVD) is a major contributor to intracerebral hemorrhage in the aging human
brain. The two most common sporadic forms of CSVD are cerebral amyloid angiopathy (CAA) and
arteriolosclerosis. By the time CSVD is diagnosed during life, the underlying small vessel pathology has
already advanced to end-stage disease. There are currently no treatments that target the final steps leading up
to vessel rupture and hemorrhage. This proposal builds on recent key observations from the applicant’s lab
suggesting immune-mediated vascular remodeling and reduced β-amyloid in individual vessels associated with
microhemorrhages in CAA. This project will test the overarching hypothesis that perivascular inflammation
contributes to vascular remodeling, resulting in vessel rupture and hemorrhage in CAA. Understanding these
fundamental pathophysiological mechanisms may uncover novel targets for much needed treatment strategies.
This project will leverage well-characterized autopsy cases of patients with a neuropathologically confirmed
diagnosis of CAA and other forms of sporadic and hereditary CSVD to determine shared pathways. The
complementary use of quantitative neuropathology in human brain tissue samples with longitudinal in vivo two-
photon microscopy in mouse models with CAA will allow studying the sequence of events leading up to vessel
wall remodeling and hemorrhage in real-time. If successful, the outcomes of this project are expected to have
high impact, because 1) the analyses are targeted at the disease stage present at the time CSVD is
diagnosed, 2) inflammatory pathways have substantial likelihood to be ‘druggable’ (i.e. response to candidate
intervention), and 3) since arteriolosclerosis also seems to entail a gradual loss of normal vessel wall
components followed by remodeling and vessel rupture, there is high potential for the results of the CAA study
to generalize to the other common CSVD.

Public health relevance
Project Narrative The proposed research will test the overarching hypothesis that perivascular inflammation and vascular remodeling contribute to hemorrhage formation in cerebral amyloid angiopathy, and that this mechanism is shared with other non-amyloid cerebral small vessel diseases. We will use complementary neuroimaging techniques including ex vivo MRI-guided histopathological investigations in post-mortem human brain tissue and longitudinal in vivo two-photon microscopy in mouse models. Successful completion of these aims will not only increase our understanding of the fundamental mechanisms that cause hemorrhages in cerebral small vessel diseases, but it will also reveal novel targets for intervention studies aimed to halt the final stages of the disease process.